Technology Enhanced Substance Use and HIV Service Navigation for Sexual and Gender Minority Young Adults Surveilled by the Carceral System

Project Summary/Abstract
There is a strong scientific premise for the study of integrated substance use disorders (SUDs) and HIV-
prevention interventions for individuals surveilled by the carceral system (CS). SUDs lead to increased rates of
CS involvement as well as increased risk for HIV-acquisition. Estimates of the proportion of the CS-involved
population with a SUD reach 72%, and ~150,000 persons with HIV pass through a detention facility annually.
Individuals with a self-reported sexual or gender minority (SGM) identity are overrepresented in the CS, and
experience well established HIV and substance use inequities. Although pre-exposure prophylaxis (PrEP) is a
proven effective intervention for HIV-prevention, its maximal impact depends on uptake, and adherence among
those at high risk. To date, few published studies have examined substance use treatment and HIV-prevention
uptake among CS-involved populations, including among SGM adults. Peer-led navigation interventions have
demonstrated efficacy in building trust and reducing barriers to healthcare engagement, and hold strong potential
to address multiple, and complex barriers to treatment and HIV-prevention linkage for SGMYA surveilled by the
CS. eHealth approaches to SUD and HIV prevention also hold promise because they improve access to effective
intervention services, particularly for SGM groups and younger people. As a multidisciplinary team with expertise
in behavioral health (substance use, mental health, HIV prevention), SGM and CS involved adults, and eHealth
enhanced and navigator-led behavioral health interventions, we propose to address notable gaps in the literature
by expanding the aims of our parent award to examine the feasibility and acceptability of an eHealth enhanced
navigator-led SUD and HIV-prevention referral and linkage intervention for SGMYA surveilled by the CS. Study
aims are to: 1) Tailor the content and structure of an eHealth technology-supported navigation intervention for
substance use treatment and HIV-prevention (PrEP) services to the unique needs of SGMYA (18 to 29 years)
surveilled by the CS; 2) Refine and test the tailored eHealth enhanced, navigator-led substance use treatment
and HIV prevention (PrEP) intervention for SGMYA surveilled by the CS, for appropriateness, satisfaction, and
fidelity. This administrative supplement appropriately expands the scope of the parent award and will directly
inform a future R01 clinical trial study to test the efficacy of the eHealth enhanced navigation intervention for
improving uptake of substance use treatment and HIV prevention services for SGMYA impacted by the CS.

Public health relevance
Project Narrative Young adults involved in the carceral system are at an increased risk of substance use disorders and HIV- acquisition. The primary objective of this administrative supplement is to expand the work proposed in the parent award by exploring the feasibility and acceptability of an eHealth enhanced navigator-led substance use treatment and HIV-prevention referral and linkage intervention tailored for sexual and gender minority young adults (18 to 29 years) surveilled by the carceral system. Given the disproportionate number of sexual and gender minority young adults surveilled by the carceral system, these settings provide an opportunity to reduce disparities in HIV and substance use treatment engagement by linking these young adults with innovative biomedical HIV prevention strategies (e.g., pre-exposure prophylaxis) and substance use treatment services. For this supplement we are requesting funding, to occur concurrently with Year 2 of the current award (R34DA054853).